Small molecule signaling in regulation of gut microbiota structure and colonization resistance

PROJECT SUMMARY
The community of commensal microbes in the gut, the gut microbiota, participates in numerous processes key
for human health, including protection against foreign microorganisms. A greater mechanistic understanding of
how the gut microbiota resists the invasion of foreign bacteria, from pathogens to new commensal
microorganisms, is essential both for the control of infection and in targeted approaches for microbiota
manipulation. Our work has shown that interpersonal differences in the gut microbiota are an important driver
of outcome of infection by Vibrio cholerae, the etiologic agent of cholera, a devastating diarrhea affecting
millions of people each year worldwide. As a genetically tractable model organism for examining invasion of
the gut microbial community, studies with V. cholerae allow for mechanistic examination of microbial
colonization and inter-bacterial interaction and competition in the gastrointestinal tract. We have shown that
small molecule signaling factors, including bacterial quorum sensing autoinducers, and microbial bile and diet
metabolites, modulates microbiota structure and in turn multiple pathways of colonization resistance against V.
cholerae. This proposal aims to define molecular mechanisms underpinning the ability of diverse human gut
communities to drive the biochemical milieu of the gut into colonization-resistant or susceptible states, thus
shaping resistance against colonization of both pathogens such as V. cholerae and new commensals. The
proposed studies aim to provide mechanistic understanding for the processes driving assembly of gut microbial
communities and identify new targets for prophylactic and therapeutic manipulations of the gut microbiota to
combat invading microorganisms.

Public health relevance
PROJECT NARRATIVE Humans and animals are colonized with commensal microbes, most densely in the gut. This community, the gut microbiota, acts as a barrier to the invasion of foreign microorganisms including pathogens. This project uses animal model systems that allow for the modification of gut microbial communities to determine how resident bacteria communicate and modify their biochemical environment to prevent infection by invading microbes. This research will open new avenues for understanding microbial biological processes within the gut and sets the stage for advances in prevention of gut bacterial infections and in modifying the microbiota to benefit human health.